Insights into Activation Mechanisms of G Protein-Coupled and Atypical β-Arrestin-Coupled Chemokine Receptors

The chemokine CXCL12 and its G protein-coupled receptor (GPCR), CXCR4, regulate cell migration during
development, immune surveillance and inflammation in normal physiology. They are also notorious for their
roles in disease, particularly cancer. Recently, the "atypical" chemokine receptor, ACKR3, was identified as a
second receptor for CXCL12 that does not signal through G proteins but instead couples to β-arrestin. Like
CXCR4, ACKR3 is expressed during development and up-regulated in cancer. Despite their medical
importance, the mechanisms by which CXCR4 and ACKR3 are activated to elicit distinct functional responses
are poorly understood. Biophysical, computational and mutagenesis studies have shown that CXCR4 and
ACKR3 recognize CXCL12 in a structurally similar manner. However, activation of CXCR4 is sensitive to even
single point mutations of the chemokine and the receptor-binding pocket, whereas virtually all ligands tested
activate ACKR3. Thus, CXCR4 and ACKR3 appear to function by different mechanisms. We hypothesize that
CXCR4 activation involves a precise network of residues that stabilize the active conformation of the receptor,
whereas ACKR3 activation occurs by a “wedge-like” mechanism, such that whenever any ligand docks in the
receptor-binding pocket, it activates by destabilizing the inactive conformation. We propose to use single-
molecule fluorescence (SMF) spectroscopy to explore the conformational dynamics and different activation
mechanisms of these two receptors. We will also investigate how ligands and effectors (G proteins and β-
arrestin) control the conformations of CXCR4 and ACKR3 and thus their signaling responses. The underlying
hypothesis is that GPCRs and ACRs are intrinsically dynamic, sampling multiple conformations, and that
ligands and effectors mutually regulate each other to influence the receptor conformation and signaling output.
Strong preliminary data support this hypothesis. Our central hypothesis will be pursued with three specific
aims. 1: Establish SMF methods to monitor the conformational dynamics of CXCR4 and ACKR3 in real-time,
and probe their mechanisms of activation. 2: Investigate structural mechanisms of ACKR3 activation and the
allostery between agonist binding and β-arrestin coupling. 3: Investigate structural mechanisms of CXCR4
activation and the allostery between agonist binding and G protein coupling. The innovation of this proposal is
that novel SMF methods will provide experimental information on receptor dynamics and allostery that cannot
be obtained with other methods. Moreover, these approaches have never been applied to chemokine
receptors and very little is known about the relationship between conformational dynamics and atypical
receptor activation. The studies are significant because they will provide unique insights into the distinct
activation mechanisms of two therapeutically important receptors, one that is a G protein-coupled receptor and
one that is β-arrestin-coupled. Understanding how ligands and effectors control the conformational state and
signaling output of these receptors should ultimately inform drug development.

Public health relevance
NARRATIVE The proposed research is relevant to public health because results from these studies will enhance understanding of the mechanisms of action of drugs that target G protein-coupled and β-arrestin-coupled receptors. New methods will be developed that provide unprecedented insight into the function of CXCR4 and ACKR3, which are important in cardiovascular development, cancer and inflammatory diseases. The results of the proposed research will advance the discovery of drugs with improved therapeutic properties and reduced side effects.